Multi-omic networks associated with COPD progression in TOPMed Cohorts

PROJECT SUMMARY
Chronic obstructive pulmonary disease (COPD) is the fourth leading cause of death in the US. Although
COPD occurs predominantly in smokers, it is unknown why only a minority of smokers (~20-40%)
develop chronic airflow limitation or destruction of distal airspaces (emphysema). The difference
susceptibility to tobacco smoke could be explained by differences in genetics or environment, which
lead to activation or repression of pathways that are important in the pathogenesis and progression of
COPD. Recent advances in high throughput omics (whole genome sequencing, DNA methylation,
RNA-Seq, proteomics and metabolomics) applied to NHLBI cohorts now permits a comprehensive
assessment of the molecular profiles of susceptible patients. This proposal will use sparse multiple
canonical correlation network analysis (SmCCNet) to integrate these existing -omics data from three
NHLBI cohorts: COPDGene, Jackson Heart Study, and SPIROMICS. The three independent cohorts
will allow replication of specific molecular networks which can be used to target new therapies or more
precise prognostic information to individuals (i.e., precision medicine). The first two of these cohorts
have large numbers of African American subjects, who are underrepresented in omics studies. We will
perform population specific analyses, which will allow us to determine which molecular signatures and
pathways might be specific to African Americans.

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) is the fourth leading cause of death in the US. To help identify why only some smokers develop COPD, this proposal will integrate recently collected extensive molecular profiles from three NHLBI cohorts (COPDGene, Jackson Heart Study, and SPIROMICS) to discover molecular networks that are important in both diagnosis and progression. In addition to non- Hispanic Whites, by focusing on African Americans, which are highly underrepresented in these types of studies, we expect that there are specific molecular network differences that may lead to specific therapies (i.e., precision medicine) based on race/ethnicity.